Translational control of gene expression in fungi

Summary
Translation of mRNA is a central cellular process, but the mechanisms that control it are not fully understood.
Up to 50% of eukaryotic mRNAs contain predicted upstream open reading frames (uORFs), but the roles of the
vast majority of these uORFs remain undetermined. In some cases, we know that this additional translational
capacity is evolutionarily conserved and serves critical functions in controlling gene expression. A special class
of these conserved uORFs encodes peptides that stall protein synthesis in response to the presence of small
metabolites. These nascent regulatory peptides act within the ribosome tunnel to arrest translation; by doing so,
they control the production of enzymes important in metabolism. However, there remain important gaps in
knowledge of the functions of uORFs. First, the mechanisms by which uORF-encoded peptides recognize small
molecules and stall eukaryotic ribosomes to control gene expression remain unclear. Second, the extent to which
uORFs are translated in cells under different conditions, the extent to which uORFs are evolutionarily conserved,
and how and why the translation of particular uORFs controls gene expression, or if their translation serves other
functions, is not known. To help bridge these gaps, we will determine the functions of a newly discovered
conserved fungal uORF peptide named the inositol regulatory peptide (IRP). Our data indicate that the IRP
regulates the expression of the first enzyme necessary for the synthesis of the important molecule inositol. We
know that the IRP, while fungal in origin, can regulate reporter genes in mammalian cells as well as the fungus
Neurospora crassa, in which we first discovered it. Using fungal and mammalian cell-free translation systems,
we obtained direct evidence for translational control by the IRP. We will use both in vivo and in vitro approaches
to determine the mechanism of action and physiological consequences of IRP function. In Aim 1, we will perform
functional analyses to determine the mechanism of action of the IRP. In Aim 2, we will perform structural analyses
to determine the mechanism of action of the IRP. Successful completion of the proposed work will provide
mechanistic information that should significantly increase our understanding of translational control mechanisms
that are generally important. It will provide new insights into regulatory and metabolic pathways that could be
important for developing strategies to manipulate metabolism to improve human health and welfare.

Public health relevance
Project Narrative Cellular nanomachines called ribosomes make proteins; they begin protein synthesis at start sites and end protein synthesis at stop sites located in mRNA, which is the blueprint they use to make protein. We and others have discovered additional start and stop sites in many RNA blueprints that direct protein synthesis but which are upstream of the main start and stop sites that direct the construction of the major protein specified in the RNA blueprint. This proposed work aims to gain a precise and complete understanding of how and why an RNA blueprint tells ribosomes to use these upstream protein synthesis sites.